Facilitating the Implementation of Population-wide Genomic Screening across Diverse Populations and Settings (FOCUS)

PROJECT SUMMARY
Population-wide genomic screening (PGS) for Hereditary Breast and Ovarian Cancer Syndrome, Lynch
Syndrome, and Familial Hypercholesterolemia offers great promise in identifying the 1-2% of the population that
unknowingly carries a pathogenic variant that puts them at elevated risk for serious, yet preventable disease.
Rapidly decreasing sequencing costs, endorsement of PGS by national bodies, and attention to precision
medicine applications have rapidly accelerated the spread of PGS programs. To date, no clear guidelines or
implementation strategies exist to support the rapid growth of PGS. Contextual factors, including program-level
procedures, organizational structure, and characteristics of the patient population, influence implementation of
these large-scale PGS initiatives. To help facilitate growth of PGS programs and enhance recruitment and
retention of representative populations into genomic initiatives, we propose to identify best practices for PGS
implementation and develop and test a freely available, online multicomponent implementation guide (FOCUS
toolkit). This project will establish a gold standard approach for equitably integrating PGS and offer the field
generalizable methods and knowledge about PGS implementation. Specifically, using a stakeholder-engaged
Implementation Mapping approach we will: 1) conduct a qualitative needs assessment among ten PGS programs
(FOCUS design sites) at various implementation stages (emerging, implementing, sustaining) guided by the
Consolidated Framework for Implementation Research integrated with constructs from the Health Equity
Implementation Framework, 2) develop and produce the FOCUS toolkit consisting of equity-focused
implementation strategies, materials, and protocols, and 3) evaluate the impact of the FOCUS toolkit on Reach,
Effectiveness, Implementation, Adoption, Maintenance and health equity outcomes for PGS in 12 PGS sites
(FOCUS test sites) with diverse populations and settings using a stepped wedge cluster randomized trial design.
All aspects of this project will be conducted by an exceptional investigative team comprised of individuals from
diverse backgrounds and across career stages and supported by a ten-person Implementation Mapping Advisory
Panel consisting of representatives from public health and regulatory agencies, communities and patient groups,
and clinical stakeholders. Efforts are further bolstered by our Plan for Enhancing Diverse Perspectives, which
advances the scientific and technical merit of our project through inclusivity and diverse perspectives among our
team, the sites where research is conducted, and those who participate in the research. These findings will: 1)
provide a standardized approach and evaluation framework for programs seeking to strategically implement and
expand population-based approaches for identifying individuals and families at high risk of serious, yet
preventable disease, 2) provide generalizable methods and knowledge about PGS, and 3) support efforts to
bring the promise of precision health to all.

Public health relevance
PROJECT NARRATIVE Population-wide genomic screening (PGS) for Hereditary Breast and Ovarian Cancer Syndrome, Lynch Syndrome, and Familial Hypercholesterolemia offers the best chance of identifying the nearly two million people in the US who have these conditions and need tailored disease prevention and clinical management. This project will use an Implementation Mapping approach to conduct a needs assessment of ten PGS programs (Aim 1), develop and produce a multicomponent implementation guide (FOCUS toolkit) to facilitate the implementation of PGS programs (Aim 2), and evaluate the FOCUS toolkit using a hybrid stepped wedge cluster randomized trial among 12 sites at various stages of implementing PGS (Aim 3). These findings will provide a standardized approach for programs seeking to strategically implement PGS and support efforts to bring the promise of precision health to all.